Ex vivo hematopoietic stem cell growth mediated by the heat shock response

ABSTRACT
Hematopoietic stem cell (HSC) transplants are used to treat several malignant and non-malignant
hematological diseases. Unfortunately, even after decades of research, HSCs cannot be well maintained or
expanded ex vivo, which has left many patients without a sufficient source of potentially life-saving HSCs.
Even short culture times in optimized conditions are deleterious to HSCs, limiting opportunities for HSC
expansion or gene editing. In preliminary studies, we established a culture system that supports sustained ex
vivo HSC growth. In this system, ten purified HSCs can be expanded into ~104 hematopoietic stem and
progenitor cells over a 10-day period, without any loss of serial long-term multilineage reconstituting activity.
The development of this culture system was based on our discovery that HSCs have lower rates of protein
synthesis than other blood cells, and that modest increases in protein synthesis impair HSC function. We
determined that increased protein synthesis impairs HSCs by reducing proteome quality. Strikingly, HSCs
exhibit a massive increase in protein synthesis in vitro that reduces proteome quality and disrupts protein
homeostasis (proteostasis). We thus sought a way to circumvent this collapse in proteostasis when HSCs are
removed from their in vivo environment so as to allow their maintenance and expansion for therapeutic
applications. The heat shock response is the principal pathway that responds to proteotoxic stress in the
cytoplasm. The master regulator of the heat shock response is Heat shock factor 1 (Hsf1). Under conditions of
proteotoxic stress, Hsf1 induces transcription of heat shock proteins that coordinate protein folding, trafficking
and degradation to promote proteostasis and cell survival. We have established that Hsf1 promotes ex vivo
HSC maintenance, as conditional deletion of Hsf1 significantly exacerbates HSC loss in vitro. Furthermore, we
identified small molecules that enhance Hsf1 activation within cultured HSCs and these small molecules
significantly enhance ex vivo HSC growth and maintenance in a Hsf1-dependent manner. Based on these
data, we hypothesize that proteotoxic stress impairs HSC self-renewal and contributes to HSC depletion in
vitro, and interventions that increase Hsf1 activity can promote ex vivo HSC growth by enhancing proteostasis
capacity. In Aim 1 we will use a suite of new technologies to test how gain and loss of Hsf1 activity influence
proteostasis within HSCs. In Aim 2 we will culture adult mouse and human HSCs in the presence of Hsf1
activators and test if these treatments enable HSC expansion by performing limiting dilution transplants. In Aim
3 we will determine how ex vivo growth influences the identity of HSCs using cell surface profiling and single
cell RNA-sequencing. Our studies represent a new approach for promoting ex vivo HSC growth by activating
the heat shock response and enhancing proteostasis capacity. Identifying a modality for HSC maintenance and
expansion holds enormous therapeutic potential for patients with diverse hematopoietic disorders.

Public health relevance
PROJECT NARRATIVE Transplantation of blood-forming stem cells can provide curative therapies for patients with diverse blood cancers, genetic and acquired anemias, bone marrow failure syndromes, immune deficiencies and autoimmune diseases. Unfortunately, even after decades of research, blood-forming stem cells cannot be well maintained or expanded outside the body, which has left many patients without a sufficient source of potentially life-saving stem cells. This proposal will examine if the inability to grow blood-forming stem cells outside the body is a consequence of dysregulated protein synthesis and homeostasis, and test if interventions that increase protein quality control and prevent the accumulation of misfolded proteins enable stem cell maintenance and expansion.